ORAL ANTIBIOTIC THERAPY IN IV DRUG USERS WITH RIGHT-SIDED INFECTIVE ENDOCARDITIS

Prospective, randomized comparison of an oral antibiotic regimen with standard intravenous antibiotic therapy in patients with right-sided endocarditis. This study will be conducted by participating members of the housestaff at Johns Hopkins.